Bioinformatics and Data Management Core

PROJECT SUMMARY BIOINFORMATICS AND DATA MANAGEMENT (BDMC) CORE
Creating and establishing the translational relevance of mouse models of late-onset Alzheimer’s disease requires
a centralized data management and analysis platform interacting with all Center components. To this end, the
Bioinformatics and Data Management Core (BDMC) will: combine human and mouse data to predict
combinations of genetic factors in polygenic models of LOAD; jointly analyze multi-omics, biomarker, and
imaging data to characterize new mouse models of LOAD; systematically align multimodal mouse data to
analogous human study data to determine the precise disease relevance of each mouse models; identify mouse
models with alterations in pathways targeted by precision therapeutics for preclinical testing; expand, maintain,
and further populate a data-sharing platform for broad and FAIR access of all data and protocols. This core will
address this goal through the following aims: (1) Iteratively analyze human and mouse data to prioritize multi-
factorial mouse models of LOAD; (2) Determine translational relevance of mouse models through alignment with
human LOAD and identification of therapeutically-relevant alterations; (3) Enable open science practices for all
Center mouse models through data dissemination and an interactive web platform. The BDMC will build upon
existing resources such as the AD Knowledge Portal, the MODEL-AD Explorer, the Agora platform, Alz-PED,
and the workflows from existing NIA-funded consortia, including AMP-AD, TREAT-AD, MODEL-AD, MOVE-AD,
and Resilience-AD. We will add the outcomes of this mouse-centered project to this foundation to optimize
translational relevance and responsible data reuse. Internal and external researchers will be positioned to
efficiently and reliably assess the disease relevance of mouse models. Finally, the broader research community
will be empowered to use responsibly use mouse models to understand and guide their research into
therapeutics for Alzheimer’s disease.